Mucosal Associated Invariant T cells in the Obese-asthma endotype

ABSTRACT
Asthma is an inflammatory lung disease that affects >300 million people worldwide. Although mild asthma is
driven by a Th2-associated, eosinophil-dominated immune response, factors such as obesity/metabolic
dysfunction are associated with more severe asthma. Thus, the “obese asthma” endotype is associated with
frequent asthma exacerbations, a shift away from Th2-dominated inflammation towards a Th17-dominated
profile, and a marked female bias. A major gap in our understanding of mechanisms driving obese asthma is
due to deficiencies in common mouse models of obesity; standard high-fat diet (HFD)-fed mouse models are
unable to induce extensive weight gain and metabolic dysfunction (associated with obesity in humans) in female
mice - a major shortcoming given the female bias observed in the obese asthma endotype. Importantly, our
group has determined that HFD feeding of C57BL/6 mice housed at a temperature in which they are at metabolic
homeostasis (thermoneutral temperature (TN); 30-33°C) promotes severe obesity and metabolic dysfunction in
female mice. Preliminary data using this model demonstrate that allergen-challenged obese asthmatic mice
demonstrate: (1) worse asthmatic outcomes compared to lean asthma controls, (2) a shift away from Th2
inflammation to a pro-inflammatory profile (Th17 or Th2/Th17), and (3) a pronounced female bias. Similar
changes are NOT observed in male mice. These data suggest that TN housed obese female asthmatic mice
model the human obese asthma endotype. Importantly, obese asthmatic female mice demonstrated a profound
increase in the frequency of IL-17A-producing cells in the lungs, particularly mucosal-associated invariant T
(MAIT) cells. MAIT cells are innate-like T cells abundant in lungs, liver, and adipose tissue. Although considered
protective in models of lean asthma, in obesity, liver and adipose tissue MAIT switch to a pro-inflammatory state
and contribute to metabolic dysfunction. In this application we hypothesize that, in obesity, liver and adipose
tissue MAIT cells become pro-inflammatory and are licensed to migrate to the lung, where they drive
severe asthma outcomes in female obese-asthmatic mice. This hypothesis will be tested in two Specific
Aims. Aim 1: To define the functional and phenotypic differences of tissue resident MAIT cells in obese
asthmatic females. We will examine patterns of MAIT cell accumulation and cytokine expression in lung and
metabolic tissue (liver, white adipose tissue) over time, quantify differential MAIT cell responsiveness to TCR-
dependent and independent signals, and perform non-biased transcriptional profiling of lung MAIT cells from
lean and obese asthmatic female mice. Aim 2: To determine the role of MAIT cells in asthma outcomes in
obese female mice. We will treat lean and obese asthmatic mice with a MAIT cell inhibitory ligand or adoptively
transfer lung MAIT cells from lean or obese asthmatic mice and assess their necessity and sufficiency on the
asthma phenotype. Completion of the proposed studies will facilitate a better understanding of the mechanisms
underlying the unique clinical parameters associated with “obese asthma” and MAIT cell biology.

Public health relevance
PROJECT NARRATIVE While clinical evidence demonstrates a unique “obese asthma” endotype that disproportionately affects women and is associated with poor health outcomes (treatment resistance, increased risk of morbidity/mortality), cellular alterations in the lungs that contribute to worsened lung dysfunction remain poorly understood. This application utilizes a novel model of obese asthma that more accurately mimics the human condition, and suggests that a unique cell population – mucosal associated invariant T (MAIT) cells – plays an important pathogenic role in obese asthma. Defining how MAIT cells influence asthma pathophysiology in obesity will not only spark innovative solutions for the treatment of asthma, but also contribute valuable knowledge to an underexplored cell type in the fields of immunology and metabolism.